Aliquot-level visual indicators of biospecimen exposure to thawed conditions

Project Summary/Abstract
Many biological analytes of interest to both clinical oncologists and cancer researchers are unstable when the
unfixed biospecimens in which they reside are exposed to thawed conditions. For example, American Society
of Clinical Oncology (ASCO)/College of American Pathologists (CAP) guidelines state that the post-excision-
up-to-fixation exposure time span for tissues collected for clinical HER2 testing in breast cancer must be less
than 1 hour. For blood plasma/serum and many types of tissue specimens that are to be frozen, the proper
cold storage temperature is well below the common laboratory freezer temperature of -20 °C. For this and
many other reasons, every year improprieties and inconsistencies in pre-analytical sample handling and
storage generate unacceptably large numbers of costly false leads in biomedical research. Unsurprisingly,
experts in the field agree that this problem must be minimized immediately. Currently there are few tools and
not so much as one widely accepted approach by which to implement evidence-based tracking of biospecimen
exposure to thawed conditions. In practice, it is actually quite rare for biomedical researchers to employ any
evidence-based QA/QC tools at all—which suggests that easy-to-use, individual aliquot-level thawed-state
indicators could have a major impact on improving biospecimen quality tracking and therefore actual quality.
Here, we will develop color change-based indicators designed for 12 different biospecimen handling/storage
requirements that ultimately will be implemented by placement into custom-designed dual-chambered, flex-
activated (like a glow-stick) see-through devices that can be housed on (notched into) the outside of a specially
designed sample storage vial. Once the bright pink color of permanganate (Mn(VII)) in the indicator turns clear
due to its reduction to Mn(II) (as easily seen from the outside of the storage vial), this indicates that the
specimen inside the vial has been exposed to a time-temperature span that is outside of the allowed
storage/handling parameters. Importantly, subsets of these indicators will not freeze until -33.5 °C or -76 °C,
facilitating the unprecedented ability to track exposures to very cold, but nevertheless improper storage
temperatures—all in a manner that will be difficult to ignore by anyone handling the samples.
Development of these indicators will be accomplished via two specific aims:
Specific Aim 1: Establish kinetic control of the permanganate/oxalate reaction system by designing reaction
starting conditions so that 12 uniquely useful time/temperature indicating solutions are developed.
Specific Aim 2: Verify that reaction kinetics and temperature sensitivities for the 12 indicators behave as
expected—that is, A) accurately, precisely (reproducibly), and with substantially increasing run times at 25 °C,
4 °C, 0 °C, and -20 °C—and B) remain accurate and precise when different stock solutions, reagent lots,
analysts, or varying periods of freezing are involved.

Public health relevance
Project Narrative Exposure of unfixed tissue or liquid biospecimens to temperatures at which they are thawed (which in many cases is well below the common laboratory freezer temperature of -20 °C) can dramatically impact clinical research results—a phenomenon that has been shown to produce an inordinate number of false leads in biomedical research. No criteria for establishing biospecimen sample integrity have been set and no quality thresholds exist that must be met before NIH/NCI (taxpayer) funds are spent on studies involving archived research specimens. This project will develop bright-pink-to-clear color change-based indicators designed for a dozen different biospecimen handling/storage requirements that, ultimately, will be implemented by placement into custom-designed dual-chambered, flex-activated (like a glow-stick) see-through devices that can be housed on (notched into) the outside of a specially designed sample storage vial—and thus kept with (but not touching) the individual specimen over the entire course of its existence.